Developmental Research Program

Project Summary/Abstract – Developmental Research Program (DRP)
The availability of mature projects of potentially high translational impact forms the cornerstone of any successful
SPORE. The Developmental Research Program (DRP) of the Fred Hutch Lung SPORE will ensure that such
projects are always available for inclusion in future iterations of the SPORE or as replacements for faltering
projects. To accomplish this, we have assembled a DRP Committee that includes a broad array of research
expertise as pertains to lung cancer. Drs. Lampe and Houghton, both SPORE project PIs will serve as the Chair
and Co-Chair, respectively. Both Drs. Lampe and Houghton serve on the Executive Committee as well, which
will ensure effective communication with SPORE leadership, as the development of new projects is such an
essential requirement for programmatic success. In conjunction with appropriate administrative support, the DRP
Committee will solicit applications and select the most highly meritorious proposals for funding. Each DRP
Awardee will be integrated into the Lung SPORE, and gain access to all SPORE core facilities. Importantly,
SPORE investigators will ensure that all DRP Awardees identify necessary collaborators for the successful
completion of the project and for guidance to reach putative translational endpoints.